Data Management and Analysis Core (DMAC) for the Air pollution disrupts Inflammasome Regulation in HEart And Lung Total Health (AIRHEALTH) Study

ABSTRACT: DATA MANAGEMENT AND ANALYTICS CORE (DMAC)
Data Management and Analytics Core (DMAC) and the overall goals that provide support to the Scientific
Human Biomarker Exposure Monitoring Core (HEMC) and Projects 1-3 by establishing and maintaining a
secure centralized system to house, share, and manage data; designing robust studies; and analyzing clinical,
mechanistic, and high-throughput data for the three PPG projects. DMAC will work with the cores and projects
to ensure that analyses resulting from clinical and mechanistic study data are performed with integrity and rigor,
using compatible definitions and metrics for smooth integration to provide interpretable findings and advance
clinical and mechanistic research for the program. Our aims are as follows. Aim 1. Provide a state-of-the-art
secure, integrated and interactive database of high-quality data generated by projects in the program that
enables wide access to study investigators. The DMAC will build a system in Research Electronic Data Capture
(REDCap) to house study data that extends the Parker Center's state-of-the-art biospecimen management
software platform to provide a PPG platform that integrates data from Projects 1-3 and the HEMC. REDCap will
integrate data from biospecimens collected for this program project with secured, associated patient metadata
for research on human tissues. DMAC will conduct quality control for all PPG data and analyses to ensure data
elements are clean. Aim 2. Design scientifically sound and robust studies across projects in the program. The
DMAC consists of personnel with expertise in designing clinical trials, longitudinal studies, and studies that
include mechanistic endpoints. The core will leverage such expertise using a team science-based approach and
refining questions and hypotheses that are feasible to develop scientifically sound analysis plans using the most
modern statistical tools that lend themselves to interpretable and meaningful findings, and to justify the number
of samples and participants necessary to address scientific questions by considering resources available during
the specified study timeline. Aim 3. Conduct analyses of clinical, mechanistic, and high throughput data. The
DMAC will develop long-term collaborative relationships with PPG investigators by embedding core members
into investigators' research teams to lead the data science component of studies. Using a well-established team
science-based approach, core members will develop and implement statistical analysis plans to address project
aims to assure findings are reproducible. The DMAC will educate PPG investigators in biostatistics and
bioinformatics most pertinent to their research to promote effective collaboration in the production of
interdisciplinary research publications. Together with the HEMC, the DMAC offers some of the most innovative
tools for bioinformatic and statistical analysis of large data sets to make the broadest and most transformative
impact in understanding clinical phenotype associations with mechanistic studies in air-pollution-associated
pathology.